Quantitative Neuroscience: From Genes to Behavior

DESCRIPTION (provided by applicant): Project Summary This is a proposal to continue a long-standing postdoctoral training program at Brandeis University. This program is designed to enhance the quantitative skills of a diverse group of investigators involved in solving the problems posed by myriad disorders of the nervous system. To understand neurological disorders and develop new therapies a cadre of outstanding investigators with strong quantitative skills working in research intensive academic institutions, in industry, and in other capacities, is required. Trainees with PhDs in mathematics, physics, engineering, and computer science will be brought into neuroscience through a program of mentored laboratory research and course work. Trainees with PhDs in the biological sciences will enter a program of mentored laboratory research and receive additional training in applying quantitative methods to understand basic and translational work in neuroscience. All trainees will participate in seminars, journal clubs, and will obtain mentoring experience and training in the responsible conduct of science. Efforts to increase the diversity of the scientific work force are described. PUBLIC HEALTH RELEVANCE: Project Narrative. Brain disorders are responsible for significant pain and suffering and economic cost. To facilitate the understanding of brain function and the development of new therapies for brain disorders, this program will produce a generation of quantitatively strong brain scientists.

Public health relevance
Project Narrative. Brain disorders are responsible for significant pain and suffering and economic cost. To facilitate the understanding of brain function and the development of new therapies for brain disorders, this program will produce a generation of quantitatively strong brain scientists.